HCMV infection downregulates nidogen 1 and myelin protein zero

ABSTRACT Human Cytomegalovirus (HCMV) is a leading cause of congenital birth defects. The most
common sequela observed in symptomatic infants is sensorineural hearing loss (SNHL). SNHL is also
observed, somewhat perplexingly, during early childhood, developing over a period of years in children
born hearing competent and asymptomatic for infection at birth. The most abundant peripheral nervous
system (PNS) myelin protein, myelin protein zero (MPZ), is largely responsible for compaction of the
PNS myelin sheath. Charcot-Marie-Tooth Type 1B and Dejerine-Sottas syndromes patients, with
mutations in MPZ, frequently suffer from late-onset SNHL, similar to that observed in HCMV
congenitally-infected children. MPZ expression is dramatically decreased in congenital HCMV-infected
tissue samples. Schwarm cells (SCs) are the only cells in the body that produce MPZ. HCMV infection of
SCs, or sole expression of the HCMV tegument protein pp71 in culture, causes large decreases in MPZ
mRNA levels. SCs express MPZ protein only when directly contacting the neurons they sheathe, making a
tractable co-culture system essential to studying defects in myelination. Substantial literature describes
rat SC/neuron co-culture; however, very little work has reported using only human cells, essential for the
study of species-restricted Human CMV pathogenesis. We have developed an all-human threedimensional
(3D) SC/neuron co-culture system, amenable to the study of HCMV interactions. Our
preliminary experiments have produced robust neurite outgrowth, SC/neuron interactions, MPZ
expression and myelination. Initial experiments with pp71-expressing SCs produced very different
interactions between the cell types and no evidence of myelination. In this application, we propose three
AIMS. AIM 1 will fully characterize the co-culture system, establishing the baseline parameters of
outgrowth and myelination, additionally assessing the functionality of the system using nerve conduction
velocity studies, over a 30-day timecourse using wildtype SCs. After defining the co-culture system's
baseline parameters, AIM 2 will assess the ramifications of HCMV infection and pp71 expression on all
parameters defined in AIM 1. AIM 3 will utilize the co-culture system to examine crosstalk between the
extracellular matrix (ECM) and myelin production, MPZ in particular, since the literature suggests a
critical link between the ECM and SCs' ability to properly myelinate neurons. We believe this 3D system
will enable us to accurately assess the effects ofHCMV infection on the developing PNS. Moreover, we
believe our new system has the potential to be utilized by the wider scientific community studying
interactions between glia and neurons and associated defects in myelination with an eye on its utilization
as an efficient platform for drug discovery and development.

Public health relevance
Project Narrative Human Cytomegalovirus is a leading cause of birth defects. Those defects can dramatically impact the lives of the children (and their parents) that suffer from them. My research is aimed at understanding the underlying mechanisms involved in the development of those defects to ameliorate and, hopefully, prevent their occurrence.